An integrative analysis of DNA methylation, transcriptomic changes, and cognitive dysfunction in Alzheimer's disease

Program Director/Principal Investigator (Last, First, Middle): Teich, Andrew Franklin Project Summary: This is a training grant that will give me the resources to develop into an academic physician-scientist. My long- term goal is to do research that focuses on Alzheimer's disease (AD) and neurodegenerative diseases of the aging brain, and integrate this with my clinical role as a neuropathologist (with at least 75% of my time dedicated to research). This grant has a scientific proposal component as well as a training component. The scientific proposal component will ask two questions. First, I will ask if there are differences in gene methylation between AD patients and cognitively normal patients with a similar cortical β-amyloid load (“pathological controls”). AD patients have been shown to have abnormalities in DNA methylation, and β- amyloid has also been shown to cause alterations in DNA methylation. However, “pathologic controls” have elevated β-amyloid levels but are not demented. Since pathologic controls have elevated β-amyloid levels, and β-amyloid has been shown to cause altered DNA methylation, pathologic controls may have some DNA methylation abnormalities normally associated with AD that do not directly cause dementia. By comparing AD brain tissue to pathological control tissue, I hope to tease out changes in gene methylation that correlate strongest with the presence of dementia. Second, I will ask whether there are changes in DNA methylation that are predictive of worsening cognitive status in the setting of AD pathology, using a patient population that is being shunted for hydrocephalus. In all, these experiments will help to tease out the association of abnormal DNA methylation with impaired cognition in AD. My PhD thesis was in a computational neuroscience lab (i.e. “dry-lab” work). I have spent the last several years after my clinical training becoming proficient in experimental neuroscience (i.e. “wet-lab” work). This training grant will take advantage of this background and train me in computational techniques of analyzing genomic and genome expression data, with a focus on applying these techniques to neurodegeneration and the aging brain. In addition, this training grant is coinciding with my elevation to Co-Director of the New York Brain Bank at Columbia University. I will accomplish four training goals during the course of this grant; 1) Acquire a skill set to facilitate my new leadership role at Columbia, 2) Acquire the skills to perform computational analysis of genomic and genome expression data, 3) Deepen my knowledge of aging biology, 4) Acquire skills to succeed in writing my first R01 grant. In summary, this training grant, through the scientific proposal and the training plan, will give me the resources to flourish as a scientist and make a contribution to Alzheimer's disease research. 0925-0001/0002 (Rev. 08/12) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Teich, Andrew Franklin Project Narrative: DNA methylation is an important mechanism by which cells regulate how their genome is expressed. I am investigating how aberrant DNA methylation may contribute to dementia in Alzheimer's disease. If we can better understand the molecular basis for dementia in Alzheimer's disease, we may be able to prevent or slow dementia by preventing or reversing these molecular changes. 0925-0001/0002 (Rev. 08/12) Page Continuation Format Page